Disruption of Excitable Axonal Domains by Glucose Metabolite Methylglyoxal

Project summary/abstract
Alterations in the excitable domains of myelinated axons, specifically the axon initial segment (AIS) and
the nodes of Ranvier, are key pathophysiologies in various neurodegenerative conditions, including diabetes.
Shortening of AIS length has been shown to lower neuronal excitability, and is also implicated in cognitive
impairment in type 2 diabetes and Alzheimer’s disease. However, the cellular and molecular mechanisms of
how these domains are altered in disease conditions remain poorly understood. This critical gap in knowledge
limits the field’s ability to manipulate the AIS and nodes for treatment. The current proposal seeks to elucidate
this important aspect of nervous system pathophysiology. The overall objective of this application is to identify
a critical molecular link in the process of AIS and nodal disruption. The prior studies and preliminary data
provided here have identified elevations in methylglyoxal (MG), a highly reactive byproduct of glucose
metabolism, as a potential mediator for AIS and nodal disruption. These data also support that calpains,
calcium-dependent intracellular cysteine proteases, are involved in this process. The central hypothesis is that
methylglyoxal disrupts AIS and nodal protein complexes via calpain activation and inhibits nervous system
function. We will test this hypothesis via three Specific Aims. Aim 1: Test the hypothesis that reduction of MG
levels with novel scavenging peptides will ameliorate AIS shortening and cognitive impairment in db/db mice,
an established model for type 2 diabetes. Aim 2: Test the hypothesis that elevated MG causes AIS/node
changes, reduced neural network activity (Aim 2A, in vitro; mouse cortical neuron culture and multi-electrode
arrays), and cognitive impairment (Aim 2B, in vivo; systemic administration of MG or inhibitor of glyoxalase 1,
an enzyme that detoxifies MG, in wild-type mice). Aim 3: Test the hypothesis that calpains mediate the effects
of MG on AIS/node structures, neural network activity (Aim 3A, in vitro; pharmacological calpain inhibition), and
cognitive function (Aim 3B, C, in vivo; genetic manipulation of calpastatin, a specific endogenous inhibitor of
calpains). Aim 3B will assess combined effects of increased MG and calpain over-activation in calpastatin
knockout mice; and Aim 3C will assess increased MG and calpain inhibition in mice over-expressing
calpastatin. This application is conceptually innovative, as we propose that the key targets of elevated MG are
the structures of the AIS and nodes of Ranvier in live neurons. Innovative use of multi-electrode arrays will
determine the effects of increased MG and AIS shortening on neural network function. The proposed research
is significant, because completion of the aims will validate MG and calpains as potential targets for translational
research aimed at treatments – such as the novel MG scavengers tested in Aim 1 – for comorbid cognitive
impairment in type 2 diabetes. These results also have potential to impact a wide variety of neurodegenerative
conditions, such as Alzheimer’s, thus ultimately providing a sustained and powerful influence on the field.

Public health relevance
Project Narrative Disruption of the excitable domains of myelinated axons is associated with a wide variety of neurodegenerative conditions – such as cognitive impairment in type 2 diabetes– in which the glucose metabolite methylglyoxal is elevated. This application will elucidate the mechanisms of how methylglyoxal affects excitable axonal domains and neuronal function by identifying a critical molecular link in this process. The proposed research is relevant to public health because it is expected to provide critical knowledge of nervous system pathophysiology needed to establishing novel treatments for a broad range of neurodegenerative conditions.